Psychosocial Palliative and Community Research in Cancer

Abstract
This T32 institutional training grant, initially awarded in 1984, was the first to provide support for
research training in psycho-oncology. Having maintained a highly productive research training
program that has kept pace with NCI research priorities and sustained a superb training record in
facilitating the early career development of a diverse and well-trained roster of fellowship
alumna(e), this grant received consecutive five-year renewals in 1989, 1994, 1999, 2004, 2009
and 2014 and 2019. It is the oldest research training program in the United States dedicated
solely to preparing new investigators for independent research careers focusing on the
psychosocial and behavioral issues across the cancer control continuum. Now in its 39th year,
this T32 Institutional Research Training Program has successfully trained a cadre of 166 early
stage investigators in psycho-oncology (132 postdoctoral and 34 predoctoral fellows) with at
least 75% of former postdoctoral trainees now building academic research careers in cancer
centers, medical centers, universities and other research settings throughout the United States.
This track record provides compelling evidence that this program continues to be one of the
foremost sites for research training in psycho-oncology. The current application requests an
additional five years of research training support. With evident growth in the depth and breadth of
the portfolio of psycho-oncology research and research training resources, there are now 17
Primary Research Mentors and 20 Other Mentors who provide depth and breadth in psycho-
oncology research and constitute our Participating Research Training Faculty. Trainees receive a
strong didactic curriculum and work in an apprentice model with the opportunity to work on a
wide variety of current and planned projects led by faculty mentors. We propose continuation of
our six postdoctoral and two predoctoral training slots. In the next five years, we intend to
enhance our training track record by some detail here to address developing opportunities in
global cancer control and financial toxicity of cancer treatments, with corresponding expansion of
these topics to research training opportunities, strengthening our didactic curriculum and building
upon our past success in recruiting and retaining under-represented scientists. Each component
of the program will be evaluated annually by participating faculty, trainees and members of an
External Advisory Committee to ensure that this program continues to serve as a national
resource for training outstanding, new investigators in psycho-oncology.

Public health relevance
Project Narrative This program continues to serve as a national resource for training outstanding new investigators in Psycho-oncology.